Chemical Analysis Core

SUMMARY/ABSTRACT: Exposure to volatile organic compounds (VOCs) is an important determinant of
maternal-offspring health, with implications for preterm birth and associated adverse health outcomes. VOCs
contaminate shallow soils and groundwater of post-industrial cities at Superfund, residential, commercial, and
industrial properties, leading to exposure via vapor intrusion. The Center for Leadership in Environmental
Awareness and Research (CLEAR) is dedicated to understanding and mitigating this serious environmental
health problem. The Chemical Analysis Core (CAC) will create a comprehensive toolbox to quantitate, monitor,
and determine the extent of VOC exposure for CLEAR research projects and the Community Engagement
Core (CEC). The CAC supports CLEAR’s mission by providing analytical knowledge, guidance, training and
new technologies designed to detect, assess and mitigate the adverse health effects emanating from chronic
and low-level exposure to VOCs. The CAC leadership and laboratory personnel will work with and within the
CLEAR project teams to ensure sensitive, accurate analyses and develop advanced techniques for VOC
analysis in novel matrices as required. Specifically, the CAC will offer precise, sensitive, low cost, high volume
quantification of VOC molecules and their metabolites, which are known or suspected to impact health.
Proteomic and adductomic analyses will identify markers of environmental exposures as well as the extent of
disease. Targeted and untargeted VOC analyses, proteomic, and adductomic workflows, which are available to
investigators through partnership with the CAC, is tailored for each of the five CLEAR projects and the CEC.
For each, analytical quantification of unique samples and new innovative sample preparation methods are an
expected outcome. The CAC integrates small molecule mass spectrometry, proteomic mass spectrometry and
high throughput cytokine analysis. These complementary analytical technologies enable the CAC to be
integrated into CLEAR research projects and facilitate assessment of the degree of exposure and VOC
exposure impacts on human health.

Public health relevance
PROJECT NARRATIVE: Chemical Analysis Core (CAC) The CENTER FOR LEADERSHIP IN ENVIRONMENTAL AWARENESS AND RESEARCH (CLEAR) has built an integrated, transdisciplinary framework, rooted in advanced techniques in environmental engineering and biomedical research, to address human exposures to volatile organic compounds (VOCs) and health risks in urban areas. The Chemical Analysis Core participates in CLEAR research projects and Community Engagement by providing analytical knowledge, training and services as well as guidance, and new technologies to measure low levels of VOCs as well as other markers of VOC exposures, which will enable CLEAR researchers to determine the degree of exposure and assess its impact on human health.